Combinatorial respiratory rehabilitation approaches to enhance breathing recovery after cervical spinal cord injury

ABSTRACT
Cervical spinal cord injury (SCI) disrupts neural pathways to spinal respiratory motor neurons, causing impaired
breathing and even death. New treatment strategies are desperately needed to improve breathing ability after
cervical SCI. Since most SCIs are incomplete, meaningful functional recovery can be induced by harnessing the
intrinsic capacity for neuroplasticity, strengthening spared neural pathways to respiratory motor neurons.
Therapeutic acute intermittent hypoxia (tAIH) is a simple, safe and effective means to induce respiratory motor
plasticity and improve breathing ability in rodent models of acute cervical SCI but is considerably less effective
with chronic injury. However, tAIH is highly effective in non-respiratory motor systems in chronic SCI, but only
when paired with task-specific training. The impact of combined tAIH and task-specific respiratory training is
not known. Thus, our fundamental goal is to maximize breathing recovery after chronic, incomplete
cervical SCI using a combinatorial approach that pairs tAIH with respiratory training.
We propose to study two distinct respiratory training paradigms: physical exercise and exposure to elevated
levels of carbon dioxide (CO2; e.g., hypercapnia). Physical exercise increases breathing via a well-known and
reproducible phenomenon known as “exercise hyperpnea”, whereby breathing is increased in proportion to
metabolic rate and blood gas levels are regulated by a mechanism independent of chemoreceptor feedback. On
the other hand, we can elicit robust, automatic increases in breathing via hypercapnia, which may provide an
opportunity for task specific training in cases where vigorous exercise is not possible (e.g., those with limited
mobility). This unique form of respiratory training involves activation of carotid CO2 chemoreceptors and is well
tolerated and easily administered to individuals with impaired mobility. Although the mechanisms differ, both
exercise hyperpnea and hypercapnia engage neural pathways involved in automatic (vs. volitional) breathing
control, thus represent forms of automatic respiratory training. We will test the hypotheses that maximal
therapeutic benefits will be achieved when tAIH is paired with either treadmill- or hypercapnia-based respiratory
training. We will test our working cellular model concerning mechanisms of synergy between tAIH and task-
specific training, which we hypothesize converges on spinal BDNF/TrkB signaling in phrenic motor neurons.
Lastly, we predict lasting changes in the neural circuits innervating phrenic motor neurons, shifting the balance
of excitatory vs inhibitory inputs, and ultimately increasing their excitability and overall motor output.
These are the first studies to pair tAIH with respiratory training that targets automatic respiratory control, which
is critical for restoring independent breathing ability. This research will inform future clinical trials as we seek
potent and enduring recovery of breathing ability after chronic SCI. Indeed, our team has a documented history
of translation, and we are actively translating highly novel discoveries from preclinical models to persons with
SCI. Thus, in a very real sense, our work will help accelerate translation of promising ideas into clinical practice.

Public health relevance
PROJECT NARRATIVE Repetitive exposure to therapeutic acute intermittent hypoxia (tAIH) restores breathing in rodent models of acute cervical spinal cord injury (SCI) but is less effective with chronic injury. However, in non-respiratory motor systems, tAIH is highly effective with chronic SCI, but only when paired with task-specific training. Our fundamental goal is to enhance breathing recovery in chronic SCI by pairing tAIH and respiratory task-specific training paradigms that target neural circuits controlling automatic (vs. volitional) breathing behaviors in chronic SCI, since effective automatic breathing function (e.g., spontaneous ventilation, ability to respond to respiratory challenges) is critical for normal, independent breathing.